Neural processing of status signals in social hierarchies

PROJECT SUMMARY/ABSTRACT
Social perception is a fundamental feature of social communication. The ability to recognize social cues of
others is critical to forming meaningful social relationships. Deficits in social perception can lead to impaired
social coordination, resulting in loneliness and isolation that severely impacts well-being. This coordination is
evident within the dynamic social interactions that occur in social hierarchies. In social hierarchies, individuals
need to recognize social cues related to status (status signals) and use this information to determine how they
socially interact. However, our knowledge of how the brain receives and transforms status signals into
socially competent behavioral output remains limited. We have demonstrated that male and female mice
form highly linear social hierarchies where each individual has a unique rank and shows appropriate social
behavior to higher and lower ranked individuals. We have also found that the medial amygdala (MeA) and the
ventral premammillary nucleus (PmV) show differential patterns of neural activity when individuals are exposed
to dominant versus subordinate olfactory status signals. Based on these findings we hypothesize that social
signal responsive neurons exist in the MeA and PmV that processes social status information before
sending outputs to downstream hypothalamic nuclei which guide the expression of behavior.
We will combine our innovative social hierarchy paradigm with cutting-edge molecular tools to test this
hypothesis in males and females. In Specific Aim 1, we will test if the MeA and PmV contain neuronal
subpopulations that are sensitive to status signals. Using single nucleus RNA-Seq (snRNA-Seq) we will
measure the transcriptional activation of MeA and PmV cells. Using cellular compartment analysis of temporal
activity by fluorescent in situ hybridization (catFISH) in conjunction with RNAScope we will characterize spatial
and temporal transcription patterns in the MeA and PmV in response to status signals. Using this approach, we
will be able to determine if distinct or overlapping neuronal subpopulations process dominant and subordinate
social signals. In Specific Aim 2, we will use vivo morpholinos to directly test the role of oxytocin and
vasopressin receptors in the MeA and PmV in coordinating social status perception. These receptors have a
well-established role in social behavior and are expressed in the MeA and PmV. We will selectively reduce the
translation of each receptor type, and then test how this manipulation impacts the ability of animals to engage
in social discrimination and maintain social dominance relationships. If successful, results from these studies
will establish a novel paradigm for understanding the neural processing of social perception, establish the MeA
and PmV as key brain regions in the discrimination of social signals, identify subpopulations of neurons that
respond to status cues, and determine the roles of oxytocin and vasopressin 1a receptors in these regions in
transforming social signals into contextually appropriate social behavior. This work will provide a strong
foundation for a productive research program investigating the neurobiology of social perception.

Public health relevance
PROJECT NARRATIVE Social perception is a fundamental feature of social communication, with impairments in this process leading to an inability to form meaningful and stable relationships, severely affecting individuals’ physical and mental well- being. Yet, how the brain perceives and transforms social cues into socially appropriate behavior remains poorly understood. This proposal will identify neuronal populations and genomic pathways in the brain that process social status cues and guide socially competent behavior enabling us to better understand the neurobiology of social perception.